Human Immunotoxicity of Developmental PCB Exposure

Emerging experimental and observational data suggest that the immune system is susceptible to the influence
of early life exposure to exogenous factors. The immune system begins to develop in utero, and continues to
undergo tightly regulated developmental processes through adolescence and early adulthood. However,
knowledge remains scant regarding how environmental exposures earlier in life modify susceptibility of immune
cells to functional deficits throughout childhood and into adolescence, especially for the human immune system.
Current evidence that environmental exposures perturb human immune function during early life is primarily
limited to infants and young children. Presently, there is almost no information about how these observations
relate to immune function during other critical developmental stages, such as adolescence. The objective of this
project is to define how exposure to a specific category of environmental agents, polychlorinated biphenyls
(PCBs), during key developmental periods, affects immune functions throughout childhood and into
adolescence. The proposed work builds directly on findings that higher infant PCB levels are strongly associated
with lower vaccine responses and greater respiratory morbidity in a birth cohort in eastern Slovakia. The
proposed work will examine adaptive immune function and infection in 400 adolescents from this cohort. Building
on our finding that 6-month PCB levels were inversely associated with anti-BCG specific antibody levels, our
first aim will determine IgG- and IgA-specific anti-BCG and -MMR levels at 45 months, and 7 and 16 years of
age. Leveraging extensive pre- and postnatal exposure data, this will allow the estimation of age-specific PCB-
antibody associations, as well as permit the estimation of vaccine response trajectory over time. This aim is
particularly important since vaccines administered in infancy are intended to create durable responses that
contribute to protection as children age. Our second aim examines PCB exposure in relation to functionality of
distinct B cell and T cell subsets. Higher PCB concentrations are associated with lower antibody levels to
vaccination in several studies. However, the mechanism is not known, and specific lymphocyte sub-types and
functional capacity remain poorly characterized: data from this aim will help fill this knowledge gap. In the third
aim, we will use PCR-based methods to measure the frequency of 22 common respiratory pathogens over a 1-
year period of follow-up, including asymptomatic and symptomatic collections. We will also abstract physician-
diagnosed lower respiratory tract infections (LRTIs) from birth through 16 years. With these measured endpoints,
associations between pre- and postnatal PCB concentrations and symptomatic and asymptomatic respiratory
infection will be assessed. By extending research with this established cohort from birth to adolescence, we will
obtain new information about how this category of common pollutants impacts the human immune system.

Public health relevance
Public Health Relevance This project addresses an issue of direct public health relevance, the findings of which will be broadly applicable to populations around the world. Altered immune function, leading to decreased vaccine responses or increased respiratory infection, is a serious global public health concern. This project will advance our understanding of how ubiquitous environmental exposures, such as polychlorinated biphenyls, affect these outcomes, moving us closer to effective primary prevention strategies to further reduce the burden of infectious disease.